Revealing cell-level gene regulation through integration of single-cell multi-omics measurements

Summary
We propose to use a visible neural network (VNN) model to identify miRNA-mRNA interactions at the single-cell
level. We will ﬁrst compare and benchmark the two types of VNN models and ﬁnd the best VNN model. Next, we will
incorporate the best VNN model into our VNN model to identify miRNA-mRNA interactions by integrating single-cell
multi-omics measurements. We expect to develop computational methods to understand better miRNA-mRNA
regulation, which would lay a solid foundation for disease diagnosis, treatment, and prevention.

Public health relevance
Narrative The mentored research aims to identify miRNA-mRNA interactions at the single-cell level. miRNA-mRNA regulation is an important process in the post-transcriptional regulation. Elucidating miRNA-mRNA regulation would help unveil the mystery of the working principle of different living organisms and provide insights for disease diagnosis, treatment, and prevention.